Advancing Student Potential for Inclusion with Research Experiences (ASPIRE)

The Advancing Student Potential for Inclusion with Research Experiences (ASPIRE) Program at the Medical
College of Wisconsin (MCW) seeks to increase diversity of the biomedical workforce with cardiovascular
research experience through a 10-week summer program for undergraduates who belong to
underrepresented groups (URGs) in science and medicine. ASPIRE will fill a great need at MCW for
federally-supported undergraduate training in cardiovascular research as MCW historically receives 200 to
300 more applications each spring from undergraduates from URGs than available summer positions. We
will provide apprentice-style mentoring for our trainees from our 36 accomplished faculty mentors embedded
within the MCW Cardiovascular Center’s thematic areas of research expertise (“Signature Programs”), which
are: 1) atherosclerosis, thrombosis, and vascular biology, 2) cardiac biology and heart failure, 3) cardio-
oncology, and 4) hypertension. Our program is designed to enhance “science identity” and disciplinary
knowledge and skills to support belonging, attitude, competence, knowledge, and skills by engaging trainees in
experiential research, personalized learning opportunities about science, technology, engineering, and
mathematics (STEM) careers (MD Track, PhD Track, or General Science Career Track), and avenues for
further training (i.e., graduate school, professional school), in addition to providing professional skills for
career advancement and tools for breaking down barriers, thriving, and resilience. We will draw on our
extensive background with the national recruitment and mentoring of trainees from URGs, leverage existing
MCW resources, and provide innovative diversity-tailored seminars and experiences in an inclusive, well-
resourced environment. With strong institutional support and excellence in cardiovascular research (ranked #13
of medical schools in funding from NHLBI), we will leverage our experienced multi-PI leadership, oversight by
an informed Advisory Committee, and culturally-aware, well-resourced faculty mentors to meet our intermediate
and long-term benchmarks of success: to enroll and train 13 sophomore, junior, or senior-level undergraduate
trainees from URGs each summer (65 trainees over the 5-year period of the award), provide tailored,
relevant, and cutting-edge training in research and professional skills, expose trainees to the multitudinous
career opportunities in STEM, enable trainees to present their research at a MCW research symposium at
the end of the 10 weeks of training (and if possible, at a national research conference the following year),
and for 80% or more of our ASPIRE graduates to complete their undergraduate degree in a STEM field,
more than 50% to apply to graduate school or other biomedical-related advanced degree programs, and
75% to obtain a first job in STEM. Overall, the ultimate goal of the ASPIRE Program is to inspire and fully-
equip our undergraduate trainees from URGs for future careers within STEM, especially in areas related to
cardiovascular research, thereby enhancing the diversity of the future biomedical workforce.

Public health relevance
PROJECT NARRATIVE This is a request for a new R25 award to support summer experiences at the Medical College of Wisconsin (MCW) in Milwaukee for undergraduate students from underrepresented groups (URGs) in science and medicine to receive hands-on cardiovascular research experiences, training in science-related skills, education about careers available in science, technology, engineering, and mathematics (STEM), and learn tools for breaking down barriers, thriving, and resilience that are tailored to the trainee’s intended career path of becoming a physician, a scientist, or working in another STEM-related career. MCW receives 200 to 300 more applications each spring semester from undergraduates from URGs than available summer positions so there is great need at MCW for federal support of this R25, and the MCW Cardiovascular Center has 36 well-trained, well-funded faculty mentors available within its four areas of research expertise in which to provide this training: 1) atherosclerosis, thrombosis, and vascular biology (plaque, blood clots, and blood vessel health), 2) cardiac biology and heart failure (heart structure and function), 3) cardio-oncology (cancer’s effects on heart and blood vessel health), and 4) hypertension (high blood pressure). At a time when the burden of cardiovascular disease continues to rise and the diversification of the biomedical workforce is greatly needed, our training program is designed to inspire and fully-equip our undergraduate trainees from URGs for future careers within STEM, especially in areas related to cardiovascular research, thereby enhancing the diversity of the future biomedical workforce.